Clinical Core

The Johns Hopkins University CFAR Clinical Core (CC) is designed to promote the generation,
maturation, and implementation of new patient-oriented, clinical and translational investigation,
with a focus on key areas for NIH-supported HIV scientific research. Our model is grounded in
our premise that new research arises when investigators can discuss clinical challenges and
these questions become successful research when incubated in a highly supportive intellectual
environment and where ample clinical research resources can be provided. The overarching goal
of the CC is to foster new HIV clinical research by providing the environment, the resources, and
the critical support necessary for the conduct of HIV-associated clinical and translational studies.
Addressing HIV-associated comorbidities and co-infections continues to be a high-priority area in
which the CC has bridged a number of scientific and clinical resources at Johns Hopkins. The mix
of HIV, aging, and substance use affecting our patients highlights the growing importance of
neurocognitive complications in HIV, an area that will have a more distinctive role with an
integration of the work of our CNS Dysfunction Scientific Working Group into the CC. The CC
has also established the capacity and expertise to support clinical research in areas that support
the goals of Ending the HIV Epidemic, including research to prevent HIV transmission through
provision of treatment, to promote HIV cure, and to reduce disparities in HIV care delivery and
outcomes. Within this framework, our Specific Aims are to: 1) Support new and established
investigators in conducting HIV patient-based clinical research. This will be done by providing
coordinated access to facilities and established databases, direct assistance in the conduct of
research by experienced coordinators, and leveraging the breadth and depth of expertise in
organ-system research at Johns Hopkins, 2) Promote interdisciplinary HIV clinical research
through coordinated exchanges of research methods and ideas among new and established
investigators. This will be done by specifically fostering the exchange of ideas and the
development of new research through a weekly HIV clinical research seminar series and other
venues, and, 3) Provide mentoring to junior and mid-level faculty to develop the next generation
of HIV clinical investigators through each step of the process from protocol development, IRB
approval, data collection, analysis and manuscript preparation, and by the linkage of junior
investigators to established senior investigators through our seminar series and direct training.
All of this is done in collaboration with the other CFAR Cores and SWGs to maximize intellectual
input and collaboration across the entire CFAR and scientific community at our institution.